Embryonic origins of T cells

PROJECT SUMMARY / ABSTRACT
T lymphocytes are adaptive immune cells that protect the host against a diverse array of pathogens. In the last
decade, immunologists have started to learn how to harness the function of T cells for immune benefit, which
has revolutionized the field of immunology and changed the way we treat a variety of immune-mediated diseases,
including cancer. However, recent discoveries in the fields of immunology and hematopoiesis suggest that our
current model of T cell development is out-of-date, which may be contributing to inefficient treatment approaches
to immune-mediated diseases. Up until now, the dogma in the field has been that all T cells are generated from
bone marrow-derived hematopoietic stem cells (HSCs), and that the T cell compartment is comprised of a single
lineage of T cells that are created equally. However, stem cell biologists have recently discovered that there are
a wide variety of non-HSC progenitors at different anatomical sites in early life that can produce T cells. In
separate studies, immunologists have learned that T cells made in early life persist into adulthood and exhibit
unique roles during infection and disease. The stem cell biologists have yet to characterize the T cells made by
non-HSC progenitors, and the immunologists have yet to map the precise hematopoietic origins of T cells found
in adulthood. Essentially, the fields of hematopoiesis and immunology are not in sync, preventing us from
updating the current model of T cell development. Our goal is thus to sync the fields, dissecting out the unique
lineages of T cells made from different non-HSC and HSC progenitors in early life to determine how the function
of T cells in adults is linked to their developmental origins. In Aim 1, we will establish what types of T cells can
be made from various embryonic progenitors. In Aim 2, we will focus on a particular type of T cells (CD8+ T
cells) and examine how their immune function and programming correspond to their derivation from non-HSC
and HSC progenitors in early life. To accomplish these goals, we will employ embryo dissections, artificial thymic
organoids, cell transplantations, and single cell sequencing, ultimately propelling us toward a new paradigm for
T cell development. Once this paradigm is established, we expect to (i) uncover lineages of T cells ideally suited
for immunotherapies, (ii) predict how patients will respond to current treatment strategies, and (iii) learn how to
fully regenerate the T cell compartment after immune reconstitution therapies.

Public health relevance
PROJECT NARRATIVE Despite our great progress, it is still impossible to predict how patients will respond to T cell therapies. The goal of our project is to identify novel lineages of T cells in the starting pool that have predictable fates, which will transform our approach to treating a wide variety of immune-mediated diseases.